Computational Tools for Proteomics

We have developed software for phosphoproteomic site-assignment and for clustering of dynamic data. We have also developed and published software to aid in the design of peptide-directed and fusion protein-directed antibodies called NHLBI-AbDesigner (http://helixweb.nih.gov/AbDesigner/). A paper describing this tool and illustrating its use has been published (Pisitkun et al. PMID: 21956165). A second paper describing its application to development of antibodies for several glomerular marker proteins has also been published (Pisitkun et al. PMID: 25328345). NHLBI-AbDesigner is currently utilized by many commercial antibody production companies. An expansion of AbDesigner is under development. We have also developed software called PhosphoLogo to produce sequence logos from phosphoproteomic data. Current efforts are aimed at the development of practical tools for application of Bayesian statistical approaches, data-mining approaches, and machine learning to large-scale physiological data. A list of available software programs can be found at http://helixweb.nih.gov/ESBL/. We have also developed several databases of proteomic and transcriptomic data to be used in kidney research (http://helixweb.nih.gov/ESBL/Database/index.html). Tools are under development for cross-referencing these databases for studies in integrative biology that are based on the Big Data concept.